The Science of Cancer Health Equity for Sexual and Gender Minority Communities

ABSTRACT
Sexual and gender minority people (SGM) experience multiple cancer-related disparities, including higher rates
of cancer risk factors, lower rates of cancer screening, higher lifetime risk of cancer, and unmet needs during
cancer survivorship. Although many national organizations, including the National Cancer Institute (NCI) and the
American Cancer Society (ACS), have stated the need for more cancer research among SGM communities,
there is currently no consensus about the highest research priorities, promising research models, or mechanisms
for collaboration between geographically dispersed scientific teams. To address this gap, we propose a two-and-
a-half day conference focused on the “Science of Cancer Health Equity for SGM Communities.” This
conference will bring together researchers, trainees, early-stage investigators, and community stakeholders to
review the current science on cancer health equity for SGM persons, identify high-priority research topics, and
develop novel approaches to engage communities and influence policy. The conference will be held at the New
York University (NYU) Langone Medical Center Campus in New York City from October 5-7, 2023. It is structured
around a transdisciplinary framework: looking within, across, and between areas of scientific expertise and
community wisdom to establish priorities. In line with this framework, we have convened a conference organizing
committee comprising two MPIs, representatives from 7 cancer centers, and a SGM Community Action Board,
with strong support from SGM community organizations such as the National LGBT Cancer Network.
Support from the NCI R13 mechanism (PA-21-151) is needed to cover speaker fees as well as travel costs
for trainees, early-stage investigators, patients and community participants. The aims of this conference
are: 1) to examine the current level of evidence informing research across the cancer control continuum for
SGM cancer patients, survivors, and caregivers; 2) to establish future research priorities across the cancer
control continuum for SGM cancer patients, survivors, and caregivers; 3) to promote the research of trainees
and early stage investigators, especially those from minoritized backgrounds, interested in research across
the cancer control continuum for SGM communities; 4) to develop a transdisciplinary network of scholars
with a focus on mentorship and on shared research methods that can address cancer health equity across the
cancer control continuum; 5) to disseminate findings from this conference, including priorities for future SGM
cancer health equity research, through a publicly available executive summary and a peer-reviewed, open
access publication. If funded, this conference will produce: (a) a publicized list of SGM cancer health equity
research priorities and (b) a network of transdisciplinary researchers and community members ready to
collaborate on projects addressing these priorities. This R13 award will also help us create an infrastructure
for future conferences to continue this work, with the next hosted by Cedars Sinai in Los Angeles in 2024.

Public health relevance
NARRATIVE Sexual and gender minority people experience many disparities before, during, and after a diagnosis of cancer. New research is needed to reduce these disparities, and new scientists need to be trained and supported in conducting this research. We will host a two-and-a-half day conference to bring together experienced researchers, trainees, and early-stage investigators interested in working to address sexual and gender minority cancer disparities, so that we can chart a course forward for research in this area.